Cardiac Pathophysiology of Proteasome Phosphoregulation

Ischemic heart disease (IHD), including acute and chronic myocardial ischemia, heart attack or acute
myocardial infarction (AMI), chronic MI, and other chronic coronary disease, is the most common cause of
heart failure (HF) in the US, afflicting the life of millions of Americans. Despite recent advances in the
intervention of IHD, the morbidity and mortality of IHD is still high; thus, a better understanding of the molecular
mechanisms by which IHD progresses to HF will facilitate the search for new measures to prevent or more
effectively delay the progression of IHD to HF. Targeted degradation of most cellular proteins, normal or
misfolded, is primarily performed by the ubiquitin-proteasome system (UPS) where the proteasome is a
molecular machine to degrade proteins purposely tagged with a chain of ubiquitin. Proteasome malfunction
and resultant accumulation of the abnormal or garbage proteins in heart muscle cells are implicated in the
progression from IHD to HF; thus, improving cardiac proteasome functioning to expedite the removal of
garbage proteins from heart muscle cells after heart attack is conceivably an attractive therapeutic strategy.
However, deployment of such a strategy is hindered currently by the lack of pharmacological means. To this
end, understanding of how proteasome function is regulated or dysregulated in IHD and what role the
(dys)regulation plays in IHD are crucial. The long-term goal of this project is to exploit proteasome regulation
for developing new therapeutic strategies. This proposal aims to determine the role of the emerging
phosphoregulation of the proteasome by protein kinase A (PKA) in AMI, ischemia/reperfusion injury (IRI), and
post-MI maladaptive cardiac remodeling and HF progression. In the last cycle, we have established first in
animals that the proteasome subunit RPN6/PSMD11 can be specifically phosphorylated at Ser14 by PKA,
resulting in marked increases in proteasome proteolytic function, taking advantage of our newly created gene-
edited mice where the phosphorylation of Rpn6 at Ser14 (pS14-Rpn6) is genetically blocked or mimicked. We
have now detected remarkable alterations in pS14-RPN6 and total RPN6 proteins in explanted failing human
hearts and mouse MI models and striking mitigation of AMI progression by genetic intervention of pS14-RPN6
in mice. Hence, we propose to use genetic approaches to unequivocally establish the mechanistic role of these
alterations in AMI, IRI, and chronic post-MI remodeling and HF. This will advance our understanding of IHD
pathophysiology and provide genetic demonstration that targeted activation of the proteasome via, for
example, compartmental stimulation of PKA could be a new treatment strategy for IHD.

Public health relevance
Project Narrative Ischemic heart disease and resultant heart failure remain the leading cause of death and disability in the US and even for the whole mankind. Impairment of the proteasome, the main molecular machine specialized in targeted protein degradation in the cell, occurs in human heart failure derived from ischemic heart disease, leading to accumulation of the proteins damaged by heart attack, and making the heart malfunctional. This project will identify and establish a proteasome enhancement mechanism as a new therapeutic strategy to prevent or slow down the progression of ischemic hearts to heart failure.